REQUEST FOR JEOL TRANSMISSION ELECTRON MICROSCOPE

Funds are requested to purchase a new JEOL JEM-1220 Transmission Electron Microscope (TEM), which will become a part of a well- established UCSB Shared Microscopy Facility. As of the fall of 1997, the only TEM on campus available to life scientists (a 13-year-old Philips CM10) became essentially inoperable. Eight principal investigators with current NIH-funded grants at UCSB depend upon TEM for their research. This interdisciplinary and interactive group of investigators come from four academic departments or research institutes, the Department of Molecular, Cellular, and Developmental Biology, the Department of Psychology, the Department of Chemistry, and the Neuroscience Research Institute. They carry on a wide range of health-related research projects. The requested electron microscope will be used to conduct ongoing and new research projects investigating retinal cell biology, developmental biology, microtubule cell biology and biochemistry, anticancer drug development, programmed cell death, and neuronal degeneration/regeneration. Each of the projects will make extensive use of the sophisticated capabilities of the JEM-1220, especially its outstanding image quality, its capability for digitization and quantitative data analyses, and its ease of operation. Ease of operation is especially important since this microscope will have multiple operators. In addition, the new TEM will be used in microscopy demonstrations for Honors Students and for undergraduates in the Cell Biology Laboratory Methods course and for the Neuropsychology course. Graduate students will receive individual training in use of the TEM through the microscopy portion of a core course and will use the microscope in their thesis research. The new electron microscope will receive considerable institutional support. It will be integrated into the UCSB Shared Microscopy Facility, and will be overseen by the Director of the facility, Dr. Brian Matsumoto, an acknowledged expert in the field of microscopy, and by Mr. Ken Linberg, who has more than 3 decades of experience in electron microscopy. In addition, the UCSB Office of Research and the College of Letters and Sciences have committed 20,000 dollars per year for three years towards the cost of maintaining the microscope. Additional years of the service contract will be provided by funds from the core budget of the Neuroscience Research Institute.